Determinants of AAV Tropism

Abstract
Adeno-associated virus (AAV)-based gene therapies have shown significant promise for the treatment of rare
diseases with unmet medical needs. In recent years, however, multiple reports of treatment-related serious
adverse events have been reported in several clinical trials. A recent U.S. Food and Drug Administration (FDA)
advisory committee meeting highlighted the impact of high vector doses on hepatic and renal toxicities
following AAV gene transfer. Hence, there is an urgent need to develop strategies to achieve therapeutic
efficacy at lower vector dosage. To achieve such, a better understanding of AAV biology in different species is
critical. During the previous funding cycle, we worked towards optimizing preclinical-to-clinical translation of
AAV vectors, which has proven difficult due to incongruent vector transgene expression profiles in different
species. To this end, our lab first developed a body of work based on structure-guided AAV evolution. Then,
we developed a novel, cross-species evolution approach, wherein AAV libraries are cycled sequentially across
mice, pigs and macaques. This approach yielded novel AAV variants that are highly potent and cross-species
compatible (ccAAVs). While the potential for clinical translation at lower vector doses using ccAAVs is exciting,
understanding the mechanism(s) underlying improved transduction efficiency is critical. Over the next 5 years,
we propose to dissect structure-function-mechanism correlates of AAV transduction in mouse and monkey
models. Specifically, we will carry out multi-trait mapping (tropism, transduction, epigenetics, transcription,
immunogenicity) of ccAAVs and related mutants in normal mice, CRISPR-based editor mice and rhesus
macaques. Specifically, we will probe the bold, new concept that AAV capsids can dictate epigenetic fate and
transcriptional activity of vector genomes across different species. Thus, the overarching goal of this
application is to better understand the structure-function-mechanism nexus in AAV biology to enable improved
vector design.

Public health relevance
Narrative The current proposal focuses on studying AAV capsid-genome interactions and the impact on transcription. We will investigate how AAV structure regulates epigenetic signatures on the genome and controls transcriptional activity of vector genomes across different species. Overall, we expect to develop a roadmap for improving AAV vector design, thereby improving therapeutic efficacy and safety of AAV gene therapies.